Urinary DNA Adductomics for the Assessment of Exposure to Cancer Risk Factors

PROJECT SUMMARY
Environmental genotoxin exposure is responsible for 80-90% of the risk of developing cancer. Indeed, Whole
Genome Sequencing studies show that human cancers carry mutational signatures reflective of the
environmental agents to which the patients were exposed. However, some studies suggest that many mutational
signatures arise from endogenous cellular processes. Mutations can arise when DNA is modified/damaged by
exogenous physicochemical agents and endogenous cellular processes (e.g., oxidation). Agent-specific
mutational signatures of environmental carcinogens reveal similarities to those found in human tumors. However,
more common are the mutations related to endogenous processes known as ageing signatures i.e., SBS1 and
SBS5. Understanding the origins of these signatures, which is key to a better understanding of cancer causes,
requires a comprehensive approach to studying adducts. DNA adductomics aims to describe the totality of
adducts in the genome, which are implicated in carcinogenesis. We hypothesize that exogenous agents act, at
least in part, via the induction of signature patterns or types of adducts, but additionally they may also influence
endogenous mutagenic processes, altering the DNA adductome. The aberrant alteration of endogenous
processes would account for the low level of agent-specific mutations in tumors despite strong evidence for the
key role of environmental agents in carcinogenesis. To begin to test this hypothesis, we will perform pilot studies
to address the following aims: Aim 1, evaluate the impact of the endogenous DNA adductome upon the
corresponding mutational landscape. In Aim 2, evaluate the impact of an exogenous environmental exposure
(benzene) upon the endogenous DNA adductome, and corresponding mutational landscape. Analysis of the
mutational landscapes, and their corresponding DNA adductome maps, will begin to advance our understanding
of the relationships between the exposome, DNA adductome and mutatome, and hence enhance the results of
the parent R01. Pursuing this route of investigation will pave the way for the identification/evaluation of cancer
risk factors and the identification of novel mutational signatures caused by exogenous/endogenous exposures.

Public health relevance
PROJECT NARRATIVE Mutations can arise when DNA is modified/damaged, and whole genome sequencing (WGS) studies show that human cancers carry mutational signatures reflective of the environmental agents to which the patients were exposed. This proposed project will use DNA adductomics and WGS to better understand what types of DNA damage lead to the mutational signatures seen following environmental exposures – helping to advance our knowledge of the role the environment in health and disease.